Strengthening Pathways between Hispanic-Serving Institutions and Leadership in Addiction Science

ABSTRACT
In 2019, Hispanic/Latinx individuals were awarded 8.6% of the 187,568 doctoral degrees awarded in the US
despite accounting for 18.5% of the US population, while African American graduates were awarded 9.2% of
doctoral degrees despite accounting for 12.5% of the population. One reason for this disparity may be that
doctoral training including training of substance use researchers tends to take place at large Research 1 (R1;
Carnegie very high research activity designation) institutions, yet the majority of underrepresented minority
(URM) students who attend college in the US are not doing so at an R1 institution. For example, 67% of
Hispanic/Latinx college students attend Hispanic-Serving Institutions (HSIs) with only 10 of the 646 HSIs in the
US designated as R1 institutions. Students who attend HSIs, because they have had less access to research
opportunity and have fewer people in their peer networks who seek graduate training, may not have had the
chance to envision a post-baccalaureate life that involves graduate training. As a result, a significant
prospective pool of exceptional students do not make their way to doctoral training programs thereby greatly
delimiting diversity among, for example, substance use researchers. To bridge the divide between HSIs and
research-intensive environments we propose to recruit URM undergraduates from HSIs in their sophomore
year to participate in a two year program at New York University (NYU) with the goal of strengthening research
capacity and supporting application to an R1 graduate school. Recruitment sites include Mercy College and
five HSIs located across NYC that participate in the City University of New York (CUNY) Macaulay Honors
College. NYU faculty and mentors include over 20 NIDA-funded investigators from diverse racial/ethnic
backgrounds. Among DDIS scholars, we aim to build skills in foundational and implementation science
research methods and knowledge of substance use research through coursework and seminars (Aim 1). DDIS
scholars will complete in-person Research Methods Weekend Workshops at NYU (monthly; academic Year 1);
online modules in substance use research (~monthly; academic Year 1); in-person/teleconferenced seminars
at NYU for ongoing skills training (weekly) and Mercy College for career development (biweekly) over the
course of the two year program. We also aim to build capacity in conducting research, completing scientific
deliverables, and applying to graduate school through a sustained, intensive mentored research experience
(Aim 2). During the junior year DDIS scholars will be matched with a NIDA-funded research mentor at NYU
and will become integrated into the lab. In the summer between the junior and senior year, DDIS scholars will
work onsite at NYU and participate in an intensive mentored research experience. Through the senior year,
mentors will support student presentations, publications, and application to graduate training. Providing
rigorous and sustained training to support completion of scientific deliverables will increase competitive entry
into a doctoral program at an R1 institution among URM scholars, thereby paving their path to independence.

Public health relevance
NARRATIVE In 2019, Hispanic/Latinx individuals were awarded 8.6% of the 187,568 doctoral degrees awarded in the US despite accounting for 18.5% of the US population, and African American graduates were awarded 9.2% of degrees awarded despite accounting for 12.5% of the population, a disparity which drives a lack of diversity among faculty at leading health institutions and in the field of substance use research. There is a need to focus on the necessary first step to increasing diversity in substance use treatment and prevention research: getting college-aged scholars of color who have been underrepresented in academic medicine and public health to attend graduate programs at Research 1 (R1; Carnegie very high research activity designation) institutions where rigorous training will enable independence. The primary innovation of this R25 proposal is its ability to deliberately build a substantial and sustainable pathway between six Hispanic-Serving Institutions and New York University to both identify and enroll exceptional underrepresented undergraduate students into a training program that will provide a pathway to doctoral training in substance use research at R1 institutions.